PTPN1 and PTPN2 as targets to improve NK function against HIV

PROJECT SUMMARY
Human immunodeficiency virus-1 (HIV-1) can be managed with anti-retroviral therapies (ART), but a cure
remains elusive. This is due to a reservoir of latently infected cells, which are established early in infection.
Elimination of these reservoirs is crucial for curing HIV. Several strategies to deplete the viral reservoirs are
under investigation, such as the shock and kill strategy, which stimulates latently infected cells into active viral
production using a latency reversal agent (LRA). This strategy allows cytotoxic lymphocytes, such as such as
CD8T cells and natural killer (NK) cells, to kill HIV infected cells, to kill HIV-infected cells. Unfortunately, these
cytotoxic cells are insufficient to clear the infection due to immune exhaustion as a result of chronic inflammation.
As a result, current research is focusing on determining molecules and signaling pathways that can boost the
cytotoxicity of effector lymphocytes.
NK cells have been shown to be important in the control of SIV and HIV infection. However, chronic HIV-
1 infection leads to pathologic changes in NK cells, including defective functionality, and control of viremia with
antiretrovirals has been reported to restore some but not all NK cells activity. Interleukin-15 (IL15) is a critical
cytokine that trigger the Janus Kinase (JAK)/ signal transducer and activator of transcription (STAT) pathway
signaling cascade, which plays a vital role in NK cell function. IL15 is particularly important for NK cell
development, differentiation, maturation, cytotoxicity, cytokine production, proliferation, and survival.
Nonreceptor tyrosine phosphatases (NTPs) protein tyrosine phosphatase nonreceptor type 1 (PTPN1) and type
2 (PTPN2) can downregulate STAT signaling pathway by dephosphorylating JAKs, STATs, and other proteins
through their catalytic domain. Previous studies in the lab have shown that targeting PTPN1 and PTPN2 with
the small molecule 3-Hydroxy-1,2,3-benzotriazin-4(3H)-one (HODHBt), enhances the effector function of CD8+
T and NK cells. In Aim 1, I will assess the role of both phosphatases controlling the activation and expression of
cytotoxic proteins in NK cells by using a newly identified double inhibitor ABBV-CLS-484 (Osunprotafib or AC-
484) and by generating CRISPR-knockouts of PTPN1 and/or PTPN2. Using a primary HIV-infected CD4 T cell
model, I will test the cytolytic activity of autologous NK cells either treated with AC-484 or CRISPR-knockouts
against a viral HIV-1 panel including subtype A, B, C, and D. In Aim 2, I will use NSG-Tg (IL15) mice to evaluate
HIV control in vivo. By understanding the critical importance of PTPN1 and PTPN2 phosphatases in NK cell
cytolytic function, we can better develop more effective cure strategies against HIV. Completion of the proposed
project will also help me to develop the necessary research and professional skills that are essential for my
career as an HIV investigator.

Public health relevance
PROJECT NARRATIVE The existence of latent reservoirs of HIV-infected cells constitutes the major impediment against viral eradication. To that end, strategies that can boost immune effector functions could enhance the efficacy of current strategies aimed towards HIV eradication. This application seeks to evaluate the role of PTPN1/PTPN2 in NK cell cytolytic activity against HIV-infected cells with the goal of using this knowledge to develop effective HIV cure strategies.